Close-loop, spatially addressable multiphoton functional imaging

Abstract
This administrative supplement will enable the PI to attract an under-represented minority in
health care research. The funding will be used for the research and training of Mr. Alejandro
Simon (currently an undergraduate student at Yale). The proposed research is under Aim 1 of
the parent grant: fast algorithms for segmentation and feedback for gain equalization.
Alejandro’s work will not only showcase the unique capability of the adaptive excitation source,
but also lay the foundation for a new class of adaptive excitation source for dynamically
changing regions of interests.

Public health relevance
Narrative This funding will be used for the research and training of an URM undergraduate student during summer of 2022. The student will develop fast algorithms for segmentation and feedback for gain equalization, laying the foundation for a new class of adaptive excitation source for dynamically changing regions of interest.